Project 5

Project 5 ABSTRACT
The effects from hazardous substances in the environment can be compounded by their
mobilization and redistribution in polluted sediment, soil, water and air following natural disasters
and emergencies. Of immediate concern is the safety of safe water and food supplies. Other threats
include soil contamination (lawns, community gardens, parks and recreational areas), along with
increased risk of human dermal and inhalation exposures near the site of the impact. A major
challenge associated with these emergencies is protecting affected communities and
neighborhoods, first responders to the disaster, frontline personnel, and those involved in the
management and cleanup of the site. Thus, the ability to rapidly minimize hazardous substance
effects during disaster events is a critical need. In Aim 1 of this proposal, multicomponent sorbents
will be synthesized from different materials and compounds that are generally recognized as safe
(GRAS), and these sorbents will tightly bind environmental chemicals and design mixtures with
high capacity and affinity. The reaction kinetics, thermodynamics and fundamental mechanism(s)
involved in interactions between the surfaces of selected sorbent materials and hazardous
environmental chemicals and mixtures will be determined using currently available in vitro methods.
Computational methods will be used to validate and provide fundamental insights, as well as to
predict sorbent properties and screen for optimum GRAS amendments, thus providing feedback
and integration with all experiments. Well-established animal and plant organisms that possess a
low tolerance for environmental chemicals in water, soil, and sediment will include the Cnidarian
model system (Hydra vulgaris), the Lemna minor (duckweed) assay, and the Caenorhabditis
elegans nematode assay. These living (in vivo) model systems will be used to predict the toxicity
of polluted samples and to validate the efficacy of our selected sorbents and our in vitro and in
silico results. In Aim 2, multicomponent sorbents will be developed that will remove hazardous
substances from contaminated food, drinking water and soil. Novel barrier formulations will be
developed for skin protection and for filter inserts in protective masks to reduce dermal and
inhalation exposures to chemicals. In Aim 3, our in vivo models will be used to evaluate real-life
environmental samples from disaster sites and well-characterized superfund sites. In these studies,
optimal sorbents and levels of inclusion that will result in detoxification of hazardous substances
will be determined. Existing collaborations with Community Engagement Core, well-established
technology transfer expertise, and interdisciplinary interactions in Project 5 will add an important
capability and dimension to the overall Center. The project-to-field pathway for the development of
broad-acting sorbents and formulations for hazardous chemicals during the course of our study has
been firmly established. We have identified relevant stakeholders and communities that will benefit
from these products. It is expected that sorbent and barrier technology developed in this research
will result in reduced chemical exposures in people and animals during disasters and emergencies.

Public health relevance
Project 5 NARRATIVE This project is developing broad-acting sorbent materials that can be used to minimize exposures to hazardous chemicals during and after environmental and man-made disasters. The outcomes of this project will be of direct use by first responders, frontline personnel, community members, and others exposed to hazardous chemical substances during disasters and emergencies. Ultimately, the strategy of using multicomponent sorbents and novel barrier formulations will effectively decrease chemical exposures through ingestion, dermal contact and inhalation.